Molecular mechanisms: Dysregulation of monoamine transporters by HIV-1Tat and cocaine

People living with HIV (PLWH) face a high risk of neurocognitive impairments in depression and experience
higher levels of impulsivity. The lifetime prevalence of cognitive depression in PLWH is twice that of HIV
seronegative individuals. Cocaine abuse has been shown to enhance the incidence of HIV-1 associated
cognitive depression and exacerbate its severity. Prolonged exposure to HIV-1 viral proteins causes
dysregulation of monoamine transmission despite the advent of combination antiretroviral therapies (cART),
which has been implicated as a key factor in developing impulsivity, cognitive depression, and cocaine abuse
among HIV positive population. Results from our previous funding cycles have demonstrated that in vivo
expression of HIV-1 Tat protein dysregulates monoamine transmission by its allosteric interaction with
dopamine (DA) transporter (DAT) and norepinephrine transporter (NET) in inducible Tat transgenic (iTat-tg)
mice. Furthermore, our preliminary in vitro and in vivo studies demonstrate that the in vivo Tat expression
increases serotonin (5-HT) release and decreases 5-HT uptake through serotonin transporter (SERT) in the
midbrain of iTat-tg mice, however, EcoHIV infection decreases 5-HT release in the midbrain and SERT-
mediated 5-HT uptake in hippocampus of humanized mice for chronic HIV infection. These findings suggest
that HIV-1 viral proteins dysregulate monoamine homeostasis via inhibition of monoamine transporters, which
may potentially increase vulnerability to developing impulsivity, cognitive depression, and cocaine abuse in
HIV-infected individuals. Studying single Tat protein allow us to identify targets in the brain for Tat binding and
develop therapeutic intervention for HIV-induced neurological damages. Indeed, a novel allosteric inhibitor of
monoamine transporters, SRI-32743, attenuates not only Tat-inhibited DA transport via DAT but also 5-HT
uptake via SERT, and alleviates Tat-potentiated cognitive impairments and depressive-like behaviors. We
hypothesize that HIV-1 Tat, acting via the unique binding sites, perturbs the monoamine transporter regulatory
network and exacerbates cocaine-induced pathophysiological changes in monoaminergic transmission,
resulting in impulsivity and depressive-like behaviors in the context of NeuroHIV. Three specific aims are
proposed in investigating this hypothesis: (1) through computational modeling and experimental validation,
identify the recognition binding pockets on human SERT for Tat, cocaine, allosteric modulator and explore the
potential interactions with Tat and cocaine, (2) characterize the pathophysiological role of the SERT in Tat- and
cocaine-dysregulated monoaminergic transmission, and (3) perform the proof-of-concept studies using a
pharmacological approach with chemical probes to establish their potential for therapeutic application in
treating impulsivity and depression. Collectively, this proposal is anticipated to provide both new therapeutics
and mechanistic insights into how HIV promotes dysregulation of monoamine transmission in the context of
poor impulsivity control, cognitive depression, and cocaine abuse.

Public health relevance
Despite the widespread use of efficacious antiretroviral therapies in controlling peripheral infection and improving life of HIV patients, impulsivity, cognitive depression has become an urgent issue in in people living with HIV (PLWH) in concurrent with substance use. In the United States, approximately 39% of HIV-infected individuals are reported to suffer from depression and the lifetime prevalence of depression in PLWH (11.9%) is twice higher than in the general population (4.6%). This project will determine a novel, previously uncertain molecular mechanism(s) driving Tat-induced dysfunction of monoamine system by direct interaction with serotonin transporter, which is associated with Tat-induced impulsivity and depression-like behavior.